Tumor tissue crosstalk in the macroenvironment of pancreatic cancer cachexia

Progressive weight loss also known as cancer cachexia, afflicts ~85% of patients with pancreatic ductal
adenocarcinoma (PDAC). Cachexia associates with treatment toxicity, morbidity, and mortality, contributing to
the 91% 5-year mortality among patients with PDAC. Moreover, while most patients with PDAC die with
cachexia, we posit that many or most die of cachexia. Currently there are no approved treatments for cachexia,
although pre-clinical studies demonstrate that preserving fat and muscle can prolong function and life with and
without chemotherapy. Here we show a novel pathway linking tumor, adipose, and muscle. We show that
PDAC tumors express Interleukin-6 (IL-6), which circulates to fat, causing local inflammation and further
secretion of IL-6. IL-6 also circulates to muscle, inducing feed-forward production of IL-6 and shedding of the
IL-6 receptor (sIL6R). Muscle-derived IL6R circulates to fat, initiating trans-signaling and adipocyte lipolysis.
Products of lipolysis are taken up by skeletal muscle, leading to myosteatosis, lipotoxic stress, and muscle
atrophy. Inhibition of tumor IL-6 reduces adipose wasting and prevents muscle loss, demonstrating a key role
for IL-6 in the PDAC macro-environment. Preliminary data from patients shows IL-6 expression in tumors,
identifies IL-6 as an upstream regulator in blood, demonstrates IL-6 and IL-6R in adipose tissue, and
documents a STAT3/NF-kB gene signature in muscle. However, only a subset of patients showed elevated IL-
6 pathway activation, whereas 85% of patients experience cachexia. This suggests that IL-6-induced
inflammation might be a driver in a subset of patients, potentially linked to tumor production of IL-6. Indeed, our
preliminary data using orthotopic xenografts of human tumors in mice indicates that patient tumors have
differing intrinsic abilities to cause cachexia, which might be related to IL-6 expression from the tumor. Here
we will interrogate human tissue specimens to document the diversity in the cachexia phenotype and to identify
patients with IL-6 pathway activity. As well, we will as use patient-derived orthotopic xenografts in mouse
models to evaluate the intrinsic ability of tumors to cause cachexia and the therapeutic potential of blocking IL-
6 trans-signaling and tissue crosstalk. To do so we will leverage our existing cachexia biorepository and our
lines of PDAC cachexia “avatars”—mice implanted with human tumor fragments.
AIM 1: Interrogate phenotypic and molecular heterogeneity and tumor-tissue crosstalk in biospecimens from
patients with well characterized body composition and pancreatic cancer cachexia.
AIM 2: Evaluate functional heterogeneity in the capacity of individual tumors to cause cachexia
AIM 3: Test the importance of tumor-tissue crosstalk via IL-6 trans-signaling and lipolysis in a pre-clinical
mouse hospital setting.

Public health relevance
The majority of patients with pancreatic cancer will experience progressive and profound loss of adipose tissue and skeletal muscle. This condition, known as cachexia, increases treatment toxicity, reduces function, and causes some 25-30% of cancer deaths. Feeding is insufficient to prevent weight loss in patients with pancreatic cancer because the tumor orchestrates changes in whole body metabolism and inflammation. Here we seek to use specimens from patients with pancreatic cancer to interrogate the cross-talk between tumor, adipose tissue, and skeletal muscle in order to validate pathways discovered using mouse models. Using a “mouse hospital” of mouse cohorts implanted in the pancreas with a number of patient-derived tumor lines and treatment with standard chemotherapy regimens, we will also test a novel anti-cachexia therapy. These studies will provide essential clinical correlative, mechanistic, and pre-clinical data for future clinical trials.